Antibodies in the neurologic effects of COVID-19

Abstract: The neurological manifestations of SARS-CoV-2 infection, known as neuroCOVID-19,
have raised concerns regarding the underlying mechanisms and potential involvement of
antibodies. Antibodies can exert inflammatory or anti-inflammatory responses based on their
glycosylation patterns. Building upon our data, our central hypothesis is that inflammatory IgGs
associated with SARS-CoV-2 infection trigger activation and/or damage to resident brain cells
and endothelial cells, leading to disruptions in brain homeostasis. Furthermore, we propose that
these inflammatory IgGs exhibit an enrichment for autoreactivity against brain antigens. To test
this hypothesis, in Aim 1, we will elucidate the impact of inflammatory IgGs on glial cells, neurons,
and endothelial cells. By utilizing well-characterized inflammatory and anti-inflammatory IgGs
obtained from plasma and CSF of COVID-19 donors, we will assess their effects on human
induced pluripotent stemcell (iPSC)-derived astrocytes, microglia, neurons, and brain endothelial
cells. This investigation will evaluate changes in cellular phenotype, inflammatory status, and
functional integrity. In Aim 2, we will investigate the potential role of inflammatory IgGs in brain
homeostasis using chimeric human brain/mouse NSG mice. Through the infusion of labeled
inflammatory and anti-inflammatory IgGs, we will examine their trafficking into the brain,
characterize their cellular associations, and determine their impact on brain homeostasis. In Aim
3, we will determine the involvement of inflammatory IgGs in COVID-19 autoreactive responses.
Previous studies have indicated the presence of autoreactive antibodies in COVID-19, with some
reports linking them to neuroCOVID-19. However, a comprehensive understanding of the impact
of autoreactive IgGs in the context of COVID-19, particularly their brain antigen targets, remains
unclear. To address this, we will employ Omics-scale high density protein microarrays to discover
COVID-19 autoreactive antibodies in the brain. Subsequently, we will assess their effects on
resident brain cells and investigate the contribution of inflammatory IgGs to t his autoreactive
phenotype, including analysis of their glycosylation patterns. Collectively these studies will
provide valuable insights into the mechanisms underlying the neurological effects of COVID-19
and the role of antibodies in these processes. The outcomes of this research have the potential
to inform therapeutic interventions targeting the neurological complications associated with
SARS-CoV-2 infection.

Public health relevance
Narrative: We are studying the neurological effects of COVID-19, also known as neuroCOVID-19. We are particularly interested in the role of antibodies in these effects. We believe that inflammatory antibodies associated with the SARS-CoV-2 virus can cause damage to the cells in our brains and disrupt their normal functioning. These inflammatory antibodies may also have a special affinity for targeting brain cells. Through laboratory experiments and animal models, we aim to understand the role of these antibodies in neuroCOVID-19. This research has implications for developing targeted therapies for COVID-19-related neurological complications